Functional and structural studies of the transition from transcription initiation to elongation

We extend our structural mechanistic studies into eukaryotic transcription to determine the
functions of the conserved and essential Mediator complex during assembly and
disassembly of the RNA polymerase II (pol II) transcription pre-initiation complex (PIC)
and in the divergent transcription that arises from pol II promoters. Building on our recent
success in developing highly efficient in vitro reconstituted transcription system, we will
leverage this system to isolate and dissect a series of PIC-Mediator complexes
representing a range of states, from initiation, to early elongation, to complexes that might
function on divergent promoters. We will address the molecular mechanisms underlying
transitions between these states through structural and biochemical means involving cryo-
EM, cross-linking and mass spectrometry (XL-MS), and multi-wavelength analytical
ultracentrifugation.

Public health relevance
Emerging evidence from recent genome-wide studies has revealed that promoters across eukaryotes are commonly paired to drive bidirectional transcription. Work in yeast suggests bidirectional transcription could be the naïve or innate state of transcription initiation with directionality evolving due to the action of diverse pathways. Building on our initial success in developing a highly efficient in vitro reconstitution system of transcription initiation from highly purified yeast factors, we set out to further develop this system to solve the mechanism of divergent transcription through structural and biochemical dissection.